Gene circuits that control morphology in Histoplasma

Histoplasma capsulatum (Hc) is a thermally dimorphic fungus that is a primary pathogen of humans.
Hc grows in the soil in a multicellular mold form. Once inhaled, in response to mammalian body temperature,
Hc converts to a unicellular yeast form that colonizes macrophages. Temperature is a key signal that is
sufficient to trigger the switch from the soil to host form (and vice versa); in the laboratory, room temperature
promotes hyphal (mold-form) growth whereas 37ºC promotes yeast-phase growth. The long-term goal of this
research is to determine the molecular basis of how temperature regulates morphology and virulence in
thermally dimorphic fungi. By elucidating how Hc cells sense and respond to host temperature, we will define
critical molecular landmarks that promote changes in morphology as well as the expression of virulence traits.
Over the past 18 years, we have made key discoveries that illuminate the gene circuits that regulate
Hc cell fate in response to temperature. We identified four transcription factors, Ryp1, 2, 3, and 4, that
promote yeast-form growth in response to host temperature. The Ryp proteins associate with the upstream
regions of both morphology and virulence genes, indicating that they directly regulate and link essential
components of the morphology and virulence programs. We published fundamental contributions to the
understanding of regulation of cell shape and virulence in response to temperature, using RNAseq and
ribosomal profiling to comprehensively identify phase-specific transcripts and proteins. During the current
funding period, we have made critical discoveries. First, we have discovered a naturally occurring, reversible
chromosome duplication that influences filamentation in response to temperature. Cells containing the
chromosomal duplication undergo robust filamentation in liquid culture at 25ºC, whereas wild-type (euploid)
cells lacking the duplication remain as yeast for longer and take more time to initiate filamentation in response
to temperature. We have defined a critical region within the chromosomal duplication that is responsible for
enhanced filamentation, thereby providing insight into which genes on the duplication drive filamentation.
Second, we have discovered a link between Ryp2 and direct control of expression of components of the heat
shock pathway. Coupled with the observation that the highly conserved chaperone Hsp90 is required for
yeast-phase growth at 37ºC, these data strongly suggest that the Ryp factors and the heat shock pathway
intersect to drive temperature-dependent yeast-phase growth. Finally, we have made technological advances
that allow us to probe critical elements of regulation such as temperature-dependent chromatin accessibility
RELEVANCE (See instructions):
Histoplasma is a primary pathogen that infects approximately 500,000 individuals per year in the U.S. and
is a significant source of morbidity and mortality. The identification and characterization of regulatory
pathways that influence cell shape and pathogenesis will significantly advance our understanding of how
this organism responds to host signals such as temperature to cause disease.